MEGESTROL ACETATE FOR TREATMENT OF CANCER CACHEXIA

The mechanisms of action of megestrol acetate will be studied in patients with advanced cancer using a randomized, double blind, placebo-controlled study design.